Optimizing Antiretroviral Therapy in HIV

DESCRIPTION (provided by applicant): My career goals are to 1) conduct high quality clinical studies to identify optimal strategies for managing antiretroviral therapy, with an emphasis on the use of antiretroviral therapy in women; 2) to expand my research focus to include the study of mechanisms of atherosclerosis in HIV and; 3) to develop novel methods for mentoring trainees in patient-oriented research. These goals will be achieved through the conduct of randomized clinical trials and through nested mechanistic studies. The Specific Aims of my research program include: Aim 1. To identify the optimal ART regimens for women of childbearing age both domestically and internationally. Aim 2. To examine the effects of ART-related changes in immune function and inflammation on endothelial function and atherosclerosis progression in HIV infected adults starting ART. Aim 3. To examine the impact of the substitution of the integrase inhibitor, raltegravir on lipohypertrophy in women with HIV infection who are currently receiving either a protease inhibitor or non-nucleoside based treatment regimen. The studies that provide the framework for my research and mentoring include 1) A randomized trial comparing the response to non-nucleoside reverse transcriptase inhibitor based treatment to protease inhibitor therapy among women who have and have not been previously exposed to nevirapine; 2) A randomized trial comparing three compact regimens for initial therapy that does not include efavirenz; 3) A sub-study nested into the trial described in 2) designed to measure changes in carotid intima medial thickness and brachial reactivity; 4) A randomized trial evaluating the efficacy of raltegravir substitution for protease inhibitor or NNRTI based ART for the management of lipohypertrophy in women.

Public health relevance
RELEVANCE (See instmctions): HIV treatment is life-long and woridwide half of the people living with HIV are women. The studies proposed in this application will help to identify optimal treatment regimens for HIV-infected women and men and to determine how treatments compare in their impact on development of heart disease. The program will provide an opportunity to train physician scientists to conduct high quality research to address important clinical questions for people living with HIV.